Inhibiting tumor growth and metastasis in highly aggressive breast cancers with centrosome amplification

PROJECT SUMMARY
Centrosome amplification (CA) is highly prevalent in cancer and strongly associated with tumor progression
and worse prognosis in several different cancers, including breast, prostate, ovarian and lung. Centrosome
amplified cells also demonstrate increased motility and invasiveness leading to metastasis. Moreover, CA is
associated with genetic aberrations, such as p53 mutation that are commonly observed in aggressive forms
of cancers, such as the triple negative breast cancer (TNBC). Our long-term goal is to target the growth and
metastatic dissemination of aggressive breast tumors with CA that will ultimately lead to improved patient
outcome. The overall objectives of this project are to (i) inhibit tumor growth in breast cancer models with CA
via inducing centrosome de-clustering and formation of multipolar spindles upon targeting transforming acidic
coiled-coil 3 (TACC3), and to (ii) block local invasion and metastatic dissemination in CA models by
preventing cell polarization, migration and invasion upon inhibition of TACC3. The central hypothesis is that
TACC3 inhibition will, on one hand, prevent active clustering of amplified centrosomes into two spindle poles
during mitotic cell division leading to multipolar mitosis and apoptotic cell death in p53 altered cells, and on
the other hand disrupts centrosome and Golgi re-orientation, microtubule nucleation and cell polarization in
interphase cells leading to decreased migration. The rationale for this project is that TACC3 inhibition
represents a unique opportunity to eliminate the most aggressive tumors that have supernumerary
centrosomes, while sparing the normal cells. The central hypothesis will be tested by pursing two specific
aims: 1.) To inhibit tumor growth in aggressive breast cancer models with CA by targeting TACC3, and 2.)
To prevent metastasis in aggressive breast cancer models with CA by targeting TACC3. State-of-the-art
experimental settings with translatable approaches will be employed, including tumor organoids, patient-
derived xenografts and immunocompetent transgenic mouse model of advanced breast cancer that we
characterized in terms of CA. The research proposed in this project is innovative as it aims to study
mitosis/interphase-specific interactomes of TACC3 that are essential for TACC3-mediated cell division in
mitotic cells and cell polarity in interphase cells that we propose to block using our novel and highly potent
TACC3 inhibitor as well as using CRISPR-mediated knock-out. The proposed project is significant because
it is expected to provide key mechanistic and phenotypic pre-clinical data to support the notion that targeting
TACC3 concomitantly inhibits tumor growth and metastasis in breast cancer models with CA, which will then
dramatically reduce mortality rates among patient subpopulation with highly aggressive cancers.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because it represents novel and clinically-relevant potential therapeutic strategy i.e., targeting TACC3, to inhibit tumor growth and metastasis in breast cancer patients with centrosome amplification, representing a highly aggressive patient subgroup with worse survival and a high risk of developing distant metastasis. Once TACC3 is established as a potent target pre-clinically using our novel inhibitor in state-of-the-art experimental models, there is potential for significant advance in the treatment of highly aggressive breast and potentially other tumors with centrosome amplification. Thus, the proposed project is relevant to the part of the NIH’s mission that pertains to reducing illness and disability.